Elucidating the role of DNAPKcs in chromosomal break end joining and clastogen resistance

SUMMARY. Kinase inhibitors targeting the catalytic subunit of the DNA-dependent protein kinase (DNAPKcs)
are being developed to sensitize tumors to clastogenic (chromosomal-breaking) agents, such as radiotherapy.
The DNAPKcs kinase inhibitor M3814 (EMD Serono) is in clinical trials, and other new potent inhibitors have
been reported. Elucidating the role of DNAPKcs in the repair of chromosomal breaks is significant because it will
enable the identification of the contexts (e.g. tumor genetic background and treatment regimens) in which
DNAPKcs kinase inhibitors are most effective, and thereby develop biomarkers to predict tumor response.
DNAPKcs has long been recognized as important for promoting radioresistance, but its role in chromosomal
break repair has remained elusive. Namely, DNAPKcs associates with factors in the canonical non-homologous
end joining (C-NHEJ) pathway for DNA double-strand break (DSB) repair but is not required for all C-NHEJ
events (e.g. is largely dispensable for V(D)J recombination signal EJ). Furthermore, until recently, specific
assays to detect C-NHEJ of chromosomal DSBs, apart from V(D)J recombination, have not been available, due
to partial redundancy with the alternative EJ (ALT-EJ) pathway. To address this gap in technology, our laboratory
recently identified a specific hallmark of C-NHEJ. Namely, we reported that several C-NHEJ factors (i.e. XLF,
KU70, and XRCC4) are required for EJ between blunt-ended DSBs (induced by the Cas9 nuclease) that are
joined without causing insertion/deletion mutations (indels), i.e. for accurate/No Indel EJ. In preliminary data, we
show that DNAPKcs is partially required for No Indel EJ, but its role is substantially magnified in cells with XLF
reduced-function mutations (hypomorphs), including mutations in an XLF motif important for binding the KU
heterodimer and DNA. Building on these findings, we will define the role of DNAPKcs in chromosomal EJ and
clastogen resistance. In Aim 1, we hypothesize that XLF and DNAPKcs function synergistically to ensure No
Indel EJ, and this synergy is critical for clastogen resistance. We will also examine the interplay between these
two factors in DNA replication, and define the key domains of XLF and DNAPKcs important for each of these
functions. In Aim 2, we investigate the interplay between DNAPKcs and a set of KU-binding factors, as well as
ALT-EJ, on clastogen resistance and genome stability. We test whether DNAPKcs functions synergistically not
only with XLF, but also with each of four KU-binding factors (CYREN/MRI, PAXX, APLF, and WRN), for No Indel
EJ, clastogen resistance, and robust recruitment of KU to DNA damage. These studies will fill a major gap in our
understanding of C-NHEJ mechanisms. Finally, we posit that combined disruption of DNAPKcs and ALT-EJ
causes aberrant DSB end processing, leading to large deletions, and/or persistent, unrepaired DSBs, thereby
causing reduced clonogenic survival and/or clastogen sensitization. In summary, we will test the overall
hypothesis that DNAPKcs promotes accurate EJ (i.e. No Indel EJ), that its role in such EJ is magnified by defects
in a set of KU-binding factors, and that it is critical for genome stability in cells deficient in ALT-EJ.

Public health relevance
NARRATIVE. Chromosomal-breaking agents (i.e. clastogens), including ionizing radiation, remain a cornerstone of cancer therapy; nevertheless, their efficacy could be improved by inhibiting the repair of chromosomal breaks in cancer cells. Indeed, inhibitors of the DNA-dependent protein kinase catalytic subunit (DNAPKcs) are being developed for this approach; but to identify the ideal contexts for using such inhibitors, it is critical to understand the role of DNAPKcs in chromosomal break repair. Thus, our proposed studies to elucidate the mechanisms of DNAPKcs function during chromosomal break repair will support the mission of the NIH to improve cancer treatments and patient outcomes.